Modeling Hemifacial Spasm in Mice

PROJECT SUMMARY/ABSTRACT Hemifacial spasm (HFS) is a chronic neuromuscular disorder characterized
by involuntary facial muscle contractions, typically affecting one side of the face. It significantly impairs the quality
of life of patients by causing social embarrassment, functional blindness, and psychological distress. The current
treatments for HFS, such as Botulinum neurotoxin Type A (BoNT/A) injections and microvascular decompression
(MVD) surgery, provide symptom relief but do not address the underlying pathophysiological mechanisms,
resulting in recurring symptoms for many patients. One of the primary challenges in advancing the understanding
of HFS is the lack of an animal model that accurately replicates the clinical features of the disorder. Evidence
suggests that hyperactivity of the facial nerve due to demyelination is associated with HFS. However, no existing
rodent model has successfully imitated the spontaneous and involuntary nature of facial muscle contractions
seen in HFS patients. This proposal aims to develop a novel rodent model of HFS using lysophosphatidic acid
(LPA)-induced demyelination of the facial nerve roots, closely replicating the clinical manifestations of HFS. We
hypothesize that demyelination of the facial nerve root at the root entry/exit zone (REZ) leads to hyperactivity of
the facial nucleus, which drives HFS-like behavior in mice. Preliminary data strongly support this hypothesis,
demonstrating that LPA injection into the facial nerve roots leads to robust HFS-like behavior, including
asymmetrical eyelid twitching, whisker pad twitching with lip pulling, ear retraction, and forced eyelid closure.
Additionally, electromyography (EMG) revealed increased burst activity in the facial muscles, and microelectrode
array (MEA) recordings confirmed heightened activity in the facial nucleus of LPA-injected mice. To rigorously
validate the facial spasm behavior and investigate the neural mechanisms underlying HFS, we propose three
specific aims: Aim 1: Validate the HFS rodent model by employing DeepLabCut machine learning to accurately
quantify facial muscle dynamics and assess facial spasm behavior with high precision. Aim 2: Assess the
dynamics of cholinergic neurons in the facial nucleus using a viral strategy and intravital calcium imaging in Chat-
Cre mice following facial nerve root demyelination. Aim 3: Investigate the effects of optogenetic and
chemogenetic manipulation of facial nucleus activity on HFS-like behavior, determining whether modulating
neuronal hyperactivity can alleviate the neuromuscular disorder. This approach will provide mechanistic insights
into the role of the facial nucleus in HFS and identify potential therapeutic targets. Collectively, this project aims
to validate a rodent model of HFS, elucidate the underlying neural mechanisms, and pave the way for the
development of novel therapeutic strategies targeting the neural substrate involved in HFS. The insights gained
from this study could significantly impact the treatment of HFS and contribute to improving HFS patient outcomes.

Public health relevance
This project aims to develop a novel rodent model of hemifacial spasm (HFS) that closely replicates the clinical features of the disorder. By investigating the neural mechanisms underlying HFS-like behavior using cutting- edge approaches such as microelectrode array recording, EMG, optogenetics, intravital imaging and machine learning, we seek to identify key neural substrate involved in facial spasms. The findings from this research could lead to improved therapeutic strategies for managing HFS, ultimately enhancing the quality of life for affected individuals.